Scleroderma Twin Study and analysis of Estrogen in patients with dcSSc

ABSTRACT
Systemic sclerosis (SSc; Scleroderma) is a connective tissue disease of unknown etiology that is associated
with significant morbidity and mortality. It has long been presumed that SSc likely results from environmental
triggers, although these environmental insults have not been identified. The gold standard for assessing the role
of environmental and inherited genetic effects on the development of a disease is the study of twins. A cross
sectional study of twins with SSc we conducted several years ago showed a comparable concordance for
disease of approximately 5% in monozygotic (MZ) and dizygotic (DZ) twins. We propose to conduct a follow-up
study of the twin cohort to determine longitudinal concordance for disease, ANA status, and autoantibody
presence. Since epigenetic regulation has emerged as an important mechanism mediating gene expression
and the manifestation of a disease phenotype, we will also compare the DNA methylation profile of twins
longitudinally. One of the factors we recently implicated in dermal fibrosis in SSc is estrogen. Our findings show
that estrogen levels are elevated in Caucasian patients with diffuse cutaneous (dc)SSc and identified clinical
features of disease associated with elevated estrogen levels. Since dcSSc is more severe in African Americans
(AA), we now propose to measure estrogen levels in post-menopausal AA women and men of similar age with
dcSSc and identify correlates with clinical features of the disease. Our findings will significantly advance our
understanding of disease pathogenesis in SSc, propel progress in the field, and importantly provide new avenues
for research for mentees to facilitate their research and allow them to establish their own independent research
programs. These mentees will be integral participants in my program throughout the award period. I will mentor
junior physician investigators in the assessment of SSc in patients and the absence of disease in healthy twins,
evaluation of Raynaud phenomenon, detection of autoantibodies, obtaining informed consent, banking and use
of clinical samples, examination of DNA methylation profiles, measurement of estrogen, and identification of
associations with clinical variables. The mentoring goals of this application also include mentoring junior clinician
investigators in patient-oriented research, grantsmanship, manuscript writing, responsible conduct of research,
entrepreneurship and innovation, and career development. My reputation as an excellent mentor coupled with
the collaborative and supportive environment at the Medical University of South Carolina, the resources available
at the institution and via the CTSA, and the resources of the Division of Rheumatology P30 CCCR, provide the
perfect environment for attracting and training successful clinician investigators. My ultimate goal is to ensure a
pipeline of well-trained clinical investigators who will continue the mission of treating patients and identifying the
cause and cure for Scleroderma and related diseases.

Public health relevance
PROJECT NARRATIVE Systemic sclerosis (SSc) is a disease with no known cause or cure. We reported that concordance for SSc in twins is lower than that reported for other rheumatic diseases. We propose to conduct a follow-up study of concordance in the twin cohort, and to identify associations of elevated estrogen levels in the SSc phenotype. Through this award, the PI will continue to mentor junior clinician investigators to ensure a pipeline of future independent investigators with clinical research interests focused on Scleroderma.